TLT-1 intracellular function

Project Summary/Abstract
TREM Like transcript (TLT-1), is a highly abundant platelet protein that mediates the earliest
states of platelet activation. Inhibition of TLT-1 function is associated with bleeding in the
inflammatory arena; however vascular hemostasis does not seem to be adversely affected. Our
studies have shown that TLT-1 presents itself as a potential target to control thrombosis without
the introduction of bleeding. However, to pursue the therapeutic aspects of TLT-1, we must first
understand the mechanisms of TLT-1 function. This project is focused on identifying the critical
signaling motifs of TLT-1 function. To accomplish this goal, we have outlined two specific AIMs:
Aim 1: Characterize TLT-1 phosphorylation sites, Aim 2: Decipher the intracellular cues
that regulate TLT-1 trafficking in platelets At the completion of these aims we will have a
clear understanding of the importance of the platelet to regulation of edema and how we can
manipulate platelet interactions to improve disease outcomes.

Public health relevance
Narrative Platelets play important roles in health and disease. We have identified a platelet protein, called TREM Like transcript (TLT-1), that mediates leukocyte escape from the blood vessel without causing vessel damage. TLT-1 has the potential to be developed into therapeutic interventions where the immune system triggers hemostatic mechanisms such as cardiovascular disease and acute lung injury